Complement in the Pathogenesis of Autoimmune Arthritis

The complement system is a major pro-inflammatory and immunomodulatory pathway and plays a central role
in the mechanisms that drive the pathogenesis of experimental murine models of human rheumatoid arthritis
(RA). In these murine models, inappropriate complement activation that is directed to self-tissues drives initial
cellular influx into the joint as well as synovial inflammation and bone erosions. However, despite the extensive
insights into the murine disease that we have developed with support of this grant, including the activation
pathways involved, how control of the system is overcome and how individual effector pathways promote
tissue damage, we do not know how the complement system plays a pathogenic role in patients with RA.
Recent findings in our studies of the human disease have identified a prolonged preclinical phase in RA
characterized by the presence of circulating autoantibodies and mucosal inflammation that appears to drive the
initial break in tolerance to citrullinated self-antigens. Following that asymptomatic phase, where complement
activation is present in the mucosal site but not systemically, it is likely that complement activation and effector
mechanisms are then especially important as the disease transitions to the very early phases of synovitis when
circulating autoantibodies directed against citrullinated proteins initially react with antigens which develop and
are displayed in the joint. To build our understanding of the human disease and translate information from
models of disease to patients themselves, the major focus of this competing renewal proposal is to understand
how the complement system is involved in the early synovitis in RA. We are especially well positioned to
accomplish this important goal, as with other support mechanisms we are able to identify and follow subjects
from the preclinical period into the very first appearance of synovitis and the diagnosis of RA. By obtaining
synovial biopsies, a skill set also developed in our program in the last 3-4 years through other funding, and
informative blood samples from patients in this important transition period, we will work to characterize the role
of complement activation as well as its regulatory and effector mechanisms in the initial development of
inflammatory arthritis and synovitis in patients. In addition, as there are distinct sub-types of RA, designated
pathotypes, which have prognostic importance, we will determine what complement activation processes are
associated with individual pathotypes and how that influences clinical outcomes. Finally, we will focus special
attention on a major synovial cell type in human RA, which are highly inflammatory fibroblast-like synoviocytes,
whose importance is increasingly understood and for which there are reported complement signatures in
unbiased omics studies. We will define the mechanisms by which complement interacts with this cell type, both
with regard to how complement is regulated by inflammatory cytokines as well as activated, and then defining
the subsequent phenotypic changes. A major goal in these studies is to use information gained to inform the
use of current and next generation complement therapeutics in this important human autoimmune disease.

Public health relevance
Complement activation is believed to play a major role in the development of rheumatoid arthritis (RA) in humans. Studies in animal models identify specific processes that appear to allow complement to be activated and result in tissue destruction. However, important gaps remain in our knowledge of the roles of complement in patients with RA. A better understanding of the role of complement and the underlying causes of dysregulation of this pathway in patients will not only provide important translational science insights but also help to identify new targets and therapeutic approaches.